CORE: Technical Integration (STINGER) and Dissemination (Buzz) Core for COSMIIC HORNET

Our goal is to make the COSMIIC HORNET technology fully accessible to the bioelectronic community,
and to enable investigators to use their own creativity to further enhance the overall system through
component development. Technological integration and interoperability of all components of the COSMIIC
technology is ensured by the "STINGER Team", which has direct communication with four NEST projects.
Dissemination to the bioelectronic community and beyond, as well as sustainability of the open source
concept, will be developed by the "Buzz Team."
Our COSMIIC approach is based on our existing platform NNP technology and this establishes a
significant foundation of interoperability that extends throughout our proposed project. The STINGER Team is
responsible for technical oversight of all NEST Teams to ensure that the components and modules developed
can operate within the NNP network structure. The STINGER Team ensures consistent modularity throughout
the entire project in order to eliminate duplicative development and minimize all device testing and regulatory
hurdles. The STINGER Team is also responsible for essentially all software development, since software is a
"system-wide" task. In addition, the STINGER Team addresses sustainability through tasks that broaden the
applicability of the COSMIIC HORNET system.
Our entire team is fully committed to the open source concept, and the key focus of the Buzz Team is to
establish the open source website that provides document access and user community interaction. The Buzz
Team is charged with coordinating legal and regulatory oversight over the project and developing the long-term
sustainability of COSMIIC through establishing a vibrant, interactive community of users and a forward-looking
business model that maintains COSMIIC beyond the end of the three-year HORNET grant.